A Dose Escalation Study of Low Dose Aspirin for the Prevention of Recurrent Preterm Birth

PROJECT SUMMARY/ABSTRACT
Preterm birth is well established as the leading cause of perinatal mortality and a significant contributor to both
chronic medical conditions and learning/societal challenges amongst those born too soon. Though complex in
its origins, preterm birth is predominantly the result of spontaneous preterm birth and ischemic placental diseases
(preeclampsia, fetal growth restriction and abruption). Beginning in the 1980's low dose aspirin (LDA) was trialed
as a therapy for the prevention of preeclampsia. Subsequent meta-analyses of randomized controlled trials of
LDA have demonstrated its efficacy in preventing both preterm birth and other components of ischemic placental
diseases. Limited data suggest that the effect of LDA in preventing both preterm birth and preeclampsia may be
greater if therapy is begun before 16 weeks and utilizing doses >100 mg. Recently the ASPIRIN trial randomized
11,976 nulliparous women with a singleton gestation in low-middle income countries to either aspirin 81 mg orally
or an identical appearing placebo between 60/7 weeks and 136/7 weeks. This trial demonstrated a 11% decrease
in preterm birth, 25% decrease in early preterm birth <34 weeks, 11% decrease in hypertensive disorders of
pregnancy and 62% decrease in preterm delivery at <34 weeks with hypertension. Though promising, Aspirin
has yet to be fully accepted as a preventive strategy for preterm birth, whether aspirin portends efficacy in a
dose-response fashion remains unexplored, and mechanistic studies of the pathways by which LDA prevents
both preterm birth and ischemic placental disease are lacking. The proposed project is designed to overcome
these limitations.
The goal is to enroll 1,300 women with a prior preterm birth due to either spontaneous birth or indicated preterm
birth and a current singleton pregnancy between 100/7 weeks to 166/7 to a randomized clinical trial of Aspirin 81
mg orally daily and a sham (n = 650) or 162 mg orally daily (n = 650). We will test three overarching
hypotheses: (i) Women with a prior preterm birth randomized to 162 mg of Aspirin daily compared to 81 mg of
Aspirin daily will have lower rates of preterm birth; (ii) Women with a prior preterm birth randomized to 162 mg
of aspirin daily compared to 81 mg of Aspirin daily will have lower rates of ischemic placental diseases; and (iii)
Biochemical markers (Thromboxane B2, Specialized pro-resolving mediators, etc.) will correlate with clinical
outcomes. Our research group will draw upon the collective experience and leadership of the Perinatal Research
Consortium (10 academic centers), an experienced data management and statistical analysis core and a strong
biospecimen analytic core. This innovative project by combining a rigorously conducted RCT with appropriate
biospecimen analysis will both address a pressing question about one of the few therapies shown to improve
the obstetrical outcomes of preterm birth and ischemic placental diseases and provide insight to the mechanisms
of how aspirin improves outcomes.

Public health relevance
PROJECT NARRATIVE The rate of preterm birth has remained stable at 10% in the United States and it is the predominant cause of both perinatal mortality and long-term pediatric morbidity. Preterm birth is largely driven by the great obstetrical syndromes (preterm birth and ischemic placental disease), which appear to be responsive to low dose aspirin. This randomized trial is designed to test the efficiacy of dose-escalation of aspirin on recurrent preterm birth and ischemic placental disease, and evaluating the underlying mechanisms by which aspirin may impact recurrent preterm birth.